Glutamate receptor signaling pathways in the circuit integration of adult-born neurons

Adult neurogenesis in the hippocampus occurs in the well-defined neurogenic niche in the subgranular zone of
the dentate gyrus. Newborn neurons are continuously generated and mature over the course of weeks to
integrate into the hippocampal circuit. Adult-born immature dentate gyrus cells (DGCs) have unique functional
properties that give them a privileged role in circuits that define specific behaviors, and which are critical to
episodic memory formation and retrieval. In particular these neurons play important roles in an animal’s ability
to separate similar patterns and disambiguate overlapping memories, processes that become impaired during
normal aging and in neurodegenerative and neuropsychiatric disorders. Therefore, mechanisms that regulate
adult-born DGC maturation and integration are important in understanding diverse neurological disorders
including Alzheimer’s disease, schizophrenia and post-traumatic stress disorders. Kainate receptors are a
class of glutamate receptor whose contributions to heterogeneous synaptic processes are still not fully
understood. The premise of these studies is built upon foundational studies in which we discovered that the
maturation of adult-born DGCs is more rapid after ablation of kainate receptors. We found that this effect was
likely through a disruption of intracellular Cl- gradient because of an effect on a neuronal Cl- transporter. We
will fully describe the altered molecular, synaptic, and functional alterations after loss of kainate receptor
signaling and will test whether GABA disruption is causal to the altered integration of maturating DGCs into the
hippocampal circuit. We will determine how altered maturation of adult-born DGCs affects the animal’s ability
to discriminate between similar patterns and temporal overlap of episodic memories and using in vivo
microendoscope imaging correlate cellular activity to behavioral measurements in a pattern separation task.
The goal of this project is to examine a new mechanism by which glutamate receptors affect adult-born DGC
integration by modulating GABA signaling. These studies would define novel processes that regulate adult-born neurons that could underlie the known involvement of kainate receptor signaling in mechanisms of
learning and memory.

Public health relevance
Neurons are continuously born in the hippocampal neurogenic niche in the brain, and how they mature and integrate into existing circuits can have a large impact on hippocampal dependent behaviors and learning and memory. We have found that kainate receptors (a family of glutamate receptors) regulate the maturation of newborn neurons, which could account for their roles in affective behaviors and memory processes. Understanding these mechanisms will potentially provide insight into developing new therapies for age related memory disorders.